Neonatal predictors of contextualized emotion processing and risk for anxiety

PROJECT SUMMARY
Depression and anxiety are associated with overlapping dysfunctions in emotion processing, but the etiology is
not well understood. Individual differences during infancy in negative temperament—a global measure of a
child’s emotional reactivity and regulation tendencies—are associated with increased risk for depression and
anxiety. Thus, the emotional dysfunction linked to depression and anxiety appears to begin during early
infancy, yet the associated developmental neurobiology is poorly understood. A central barrier to unlocking the
developmental neurobiology of emotion dysfunction is we do not know how variation in brain function at birth
relates to emotion processing later in infancy, and whether this relation depends on infant temperament.
Contextualized emotion processing—processing emotions in the real-world, with competing stimuli and full
narrative context—is complex and includes: 1) detection of and attention towards salient stimuli; 2)
interpretation and contextualization of this information; and 3) making a behavioral response. Depression and
anxiety have been associated with dysfunctions at all three stages, and emerging evidence suggesting that
some of these dysfunctions are present at birth. Recent work has found that the variation in newborn brain
activation during saliency processing—the first stage of emotion processing—is associated with risk for
anxiety. While this links early variation in saliency processing to risk trajectories for anxiety and depression, the
developmental sequence is unknown. This study is therefore designed to identify how neonatal brain function
is associated with contextualized emotion processing during infancy. This project will add an additional
measure to the ongoing Neonatal Predictors of Anxiety Disorders Study (N-PAD; R01MH122389 PI: Sylvester,
sponsor), a longitudinal study of mothers and infants. This current grant will substantially increase the impact of
the parent grant by adding a video-watching eye-tracking task to the 24-month assessment, allowing us to
measure attention to contextualized emotional stimuli. Our central hypothesis is that neonatal activation to
salient stimuli (measured with fMRI) predicts attention to contextualized emotional stimuli during
infancy (measured with eye tracking), and this relation is strengthened in infants with negative
temperaments. Results will provide important insights to how internalizing symptoms emerge across early
development. Through this project, the candidate will develop critical expertise in infant neural and behavioral
assessments.

Public health relevance
PROJECT NARRATIVE This project will examine how early variation in naturalistic emotion processing—how we attend to, interpret, and respond to emotional cues—are linked to risk for depression and anxiety in a large longitudinal sample of infants. Specifically, we will examine how neonatal activation to salient stimuli is linked to how infants attend to naturalistic emotions, and how this association is moderated by infant temperament. This proposal will therefore provide important insight to the etiology of depression and anxiety as well as important training opportunities in infant mental health methods.